Data Management and Statistical Core

PROJECT SUMMARY - DATA MANAGEMENT AND STATISTICAL CORE
The Data Management and Statistics (DMS) Core has an essential role in all activities of the Northwestern
ADRC, whereby all information generated through ADRC operations is stored, integrated and shared in a
systematic fashion; studies are provided with design expertise, and research results are analyzed and
presented optimally. During the past 5 years, the Northwestern ADRC has devoted considerable resources to
its DMS Core in ways that have enhanced its impact on intramural activities and streamlined interactions with
NACC and extramural collaborations. During the upcoming cycle, the DMS Core will be guided by three goals:
1) To maintain an integrated and flexible state-of-the-art relational and secure database that provides
efficient access to subject-based data for approved research projects and for transmission to NACC.
2) To provide biostatistics expertise in research design and data analysis for all ADRC investigators,
including fellows, graduate students and Development Project Grant applicants.
3) To apply and develop innovative biostatistical approaches designed to address new developments within
the Northwestern ADRC.
The DMS Core has undergone a profound transformation over the last five years in response to the evolving
needs of the Northwestern ADRC, NIA, NACC, and our many research collaborators. In collaboration with the
Northwestern University Clinical and Translational Sciences Institute (NUCATS), the DMS Core established a
state-of-the-art database with a robust set of tools that assist in the capture, curation, storage, searching,
sharing, transferring and analysis of data sets generated by all components of the ADRC. In addition, the DMS
Core participates in the design and interpretation of all ADRC research projects with a quantitative component.
Statisticians provide expertise in the generation of hypotheses and analyses of the results and participate in
the writing of grant applications as needed, formulating and writing the power calculations, setting up data
collection tools, monitoring data collection, and performing statistical analyses. The DMS Core will also apply
and develop innovative biostatistical approaches designed to address new research developments within the
Northwestern ADRC. Statistical consultation is available to all senior and junior investigators, postdoctoral
fellows, and predoctoral graduate students.